NEUROHORMONAL SUBSTRATES OF SOCIAL ATTACHMENT--A PILOT STUDY

The goal is to determine whether plasma oxytocin is associated with emotional states, induced relaxation, and interpersonal traits. Forty- five healthy femail volunteers, ages 18-35 will complete questionnairs and undergo behavioral tasks in the lab. They will be tested individually in a single session of 1.75 hour duration. We request that GCRC staff place an in-dwelling catheter in the subjects forearm and draw blood samples every 20 min. (5 draws per subject).